MAINTENANCE AND COIL DEVELOPMENT FOR MR MAGNETS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. General - MR maintenance and fabrication of coils for various uses. Gary Cofer operates the equipment with all our MR studies and also maintains (and sometimes manufactures) the associated coils.